TASK ORDER 4A SITE STUDY SETUP: CTSU IDIQ

The Contractor shall provide operational, regulatory and informatics
support to the Cancer Trials Support Unit (CTSU) to conduct clinical studies across multiple institutions for Phase 0 through Phase
3 cancer-related studies to include:
1. Operational Support
2. Information (IT) Support